PHASE I IDURD AND ACCELERATED HYPERFRACTIONATED XRT FOR HIGH GRADE GLIOMAS

The purposes of this study are to assess the feasibility of continuous long term infusion of iododeoxyuridine (IdUrd) and accelerated hyperfractionated radiotherapy (XRT) in the management of high grade gliomas; to determine local and systemic toxicities of this regimen; to investigate serum levels of IdUrd; to determine the maximum tolerated dose of IdUrd; and to assess the incorporation of IdUrd in tumor and proliferating target cell.